Imaging Research

IMAGING RESEARCH SHARED RESOURCE
PROJECT SUMMARY / ABSTRACT
The mission of the Imaging Research Shared Resource (Imaging SR) has been to provide all regional cancer
investigators with comprehensive preclinical and clinical imaging capabilities and services to deliver in vivo and
in situ imaging assessments of cancer. Established in 2005, the Imaging SR has now grown to become a multi-
institutional SR with two sites at Case Western Reserve (CWRU)/University Hospitals (UH) and Cleveland Clinic
(CC) integrating comprehensive, state-of-the-art imaging capabilities for both animal models of cancer
(CWRU/UH and CC sites), as well as pediatric and adult patients (CWRU/UH site). The Imaging SR is supported
by a well-established operational and administrative infrastructure including centralized imaging facilities at each
site led by Flask, Chen and Androjna (Co-Directors) and supported by 9 highly-skilled Imaging SR staff with over
100 years of combined imaging expertise. The aims of the Imaging SR are to provide both imaging services and
training on state-of-the-art imaging systems to all regional cancer investigators including: 1) high-volume
preclinical bioluminescence and fluorescence imaging services; 2) custom-designed radionuclides for preclinical
PET imaging capabilities to assess tumor progression, therapy, and metabolism; 3) novel in situ cryo-
fluorescence imaging to direct cell/gene therapies; 4) MRI and MR Fingerprinting assessments for both mouse
cancer models and cancer patients. Importantly, imaging services at both sites are available to all regional
investigators through established, compliant inter-institutional agreements and operational processes. The
capabilities and services provided by the Imaging SR have significantly expanded during the current funding
cycle through investments by regional institutions, the NIH, and industrial collaborators including: 1) two new
research-dedicated Siemens Vida 3T human MRI scanners (CWRU/UH site, ~$5M investment by CWRU/UH
and Siemens); 2) a new Cubresa PET insert for the first small animal PET-MRI in the region (CWRU/UH site,
~$400K from NIH S10 award); 3) an upgraded 9.4T small animal MRI scanner supporting MR Fingerprinting
development (CWRU/UH site, ~$1.1M investment by CWRU); 4) a new Mediso nanoscan PET/CT (CC site,
~$900K from NIH S10 award); and 5) a new Vevo F2 rodent ultrasound to support novel nanobubble
development (CWRU/UH site, ~$400K investment by CWRU). The custom radiochemistry synthesis capabilities
provided by the CWRU/UH site are also available to both sites to support novel preclinical PET imaging studies.